Epigenetic mechanisms regulating neuron production during cortical development

The cerebral cortex is the brain region underlying human higher cognitive functions, such as complex decisionmaking,
reading and reasoning. These functions rely on networks of neurons mainly generated during embryonic
development. During that developmental period, the balance between proliferation and differentiation of neural
precursors (NPs) is critical for the generation of appropriate numbers of neurons. Therefore, disruptions of NP
proliferation are at the origin of numerous neurodevelopmental disorders, such intellectual disabilities, autism,
microcephaly and macrocephaly. Numerous cellular and molecular processes regulate proliferation vs differentiation
decisions in NPs. In the present study, we wiPll focus on epigenetic mechanisms modulating the expression of
proliferation and differentiation genes. To do this, we will focus on the transcription factor ZBTB7A, known to
mediate chromatin accessibility in the regulatory regions of genes implicated in proliferation and differentiation.
ZBTB7A has been implicated in many different systems, but its role in NPs during cortical development is completely
unknown. However, the ZBTB7A gene is located in the 19p13.3 microlocus containing 3 genes, and whose
duplication or deletion lead to microcephaly and macrocephaly, respectively. Our preliminary studies in the mouse
show that altered expression of ZBTB7A in NPs leads to proliferation deficits with predicted outcomes matching
those observed in the 19p13.3 syndrome. Altogether these findings make ZBTB7A an outstanding candidate to
discover novel epigenetic mechanisms regulating the development of the cerebral cortex. In this study we will use
mouse models mimicking ZBTB7A alterations in humans to characterize how altered expression of ZBTB7A impacts
NP proliferation and the establishment of cortical architecture. In a second step, we will characterize ZBTB7A target
genes in NPs using ChIP-seq coupled with RNA-seq. After validation of candidate genes using luciferase assays, we
will attempt genetic rescue experiments to re-establish the phenotypes caused by altered ZBTB7A levels. In a third
step we will further dissect the molecular mechanisms by which ZBTB7A regulates gene expression in NPs, focusing
on ZBTB7A co-factors. To do this, we will use BioID to identify proteins operating in the vicinity of ZBTB7A in
cortical NPs and we will use luciferase, ChIP-PCR and co-IP assays to understand the mechanism by which ZBTB7A
can affect the recruitment of those co-factors to gene regulatory region, and thus impact gene expression. This project
will advance the mission of the Pediatrics and Rare Diseases group at Sanford Research, while providing new insights
into the epigenetic mechanisms regulating the development of the cerebral cortex, and how disruption of these
mechanisms can lead to neuropediatric diseases.